Neuroimaging Informatics Tools and Resources Clearinghouse Outreach, Infrastructure, and Content Maintenance

Project Summary/Abstract The Neuroimaging Informatics Tools and Resources Clearinghouse (NITRC: www.nitrc.org) is an established and award-winning (2009 Excellence.gov award and 2015 HHSInnovates award) repository of information and support for resources relevant to a broad set of neuroimaging domains and their communities of developers and users. Resources hosted on NITRC Resources (NITRC-R) include software, hardware, and datasets, among other assets. The purpose of NITRC is to provide neuroscience researchers with a complete solution to the problem of finding, developing, and sharing neuroimaging and neuroinformatics software tools, finding and sharing large-scale resting state and structural imaging datasets, and manipulating the software and the data in high-performance computing environments. NITRC will continue to be a framework where researchers can identify software and data and seamlessly deliver them to a cloud-based computational resource for processing. This will be accomplished through the execution of aims designed to provide: 1) Content and user maintenance for the established NITRC-R, IR and CE environments; 2) infrastructure maintenance for the complete development and deployment environments; 3) content expansion in the existing domains, and identification of new areas that are amenable to NITRC support; and 4) outreach, documentation, and support for the established NITRC user base. This continued effort will greatly enhance the delivery of high-performance computing to the large-scale datasets that are becoming the mainstay of neuroscience research and promote more reproducible publication practices through enhanced resource sharing.

Public health relevance
Project Narrative The purpose of the Neuroimaging Informatics Tools and Resources Clearinghouse (NITRC) is to provide neuroscience researchers with a complete solution to the problem of finding, developing, and sharing neuroimaging and neuroinformatics software tools, finding and sharing large-scale resting state and structural imaging datasets, and manipulating the software and the data in high- performance computing environments. NITRC will continue to be a framework where researchers can identify software and data and seamlessly deliver them to a cloud-based computational resource for processing. This will greatly enhance the delivery of high-performance computing to the large-scale datasets that are becoming the mainstay of neuroscience research and promote more reproducible publication practices through enhanced resource sharing.